ND INBRE Health & the Environment

The ND INBRE and the University of North Dakota School of Medicine and Health Sciences is
proposing the purchase of a Leica Bond RX to automate immunostaining for research and
training in clinical and translational research. The UND SMHS is providing $40,000 towards the
purchase price, newly completed shell space in the medical student research laboratory, and a
staff Ph.D. to train investigators, assist in operation of the instrument, and support the use by all
stakeholders. Boarded pathology faculty in Department of Pathology will participate in the
interpretation of results. The Leica Bond RX will support the research of multiple CoBRE
awards, the DaCCoTA CTR, and multiple investigator-initiated research projects. The ND
INBRE research cores are designed to provide state-of-the-art technology that cannot be sent to
commercial vendors and must be performed “in house”. These current cores include:
microscopy (confocal, fluorescence, laser capture microdissection, and stereology); flow
cytometry (including cell sorting); and, animal behavior (including optogenetic capacity).
Biotechnology and Drug companies do use commercial vendors for immunostaining, but costs
for these commercial services exceeds the budgets of most academic research. This
technology, unless provided by ND INBRE, is also unavailable to the PUIs and TCUs which the
program is dedicated to serve. Strong cores equipped with modern technology are crucial for
North Dakota which has a low population and large land mass. The ability to engage
undergraduates at rural primarily undergraduate institutions and tribal colleges in the use of
cutting-edge technology is a mission of the ND INBRE infrastructure program.

Public health relevance
The ND INBRE is charged with providing the infrastructure to advance research and training for the next generation of researchers and health professionals. The ND INBRE has established core research and training facilities to support this goal.